Administrative Core

Project Summary
The Karmanos Cancer Institute (KCI) Detroit P20 SPORE in Cancer Health Disparities comprises two Research
Projects, three Shared Resource Core components (Administration, Biospecimen and Patient and Community
Engagement), and a Developmental Research Program (DRP). The Administrative Core provides a common
management structure for the P20 SPORE; i.e., the overall coordination of all P20 SPORE-related activities
associated with the Research Projects, Shared Resource Cores, DRP, and Advisory Boards.
Specifically, the Administrative Core will support the P20 SPORE by integrating various tasks, including 1)
providing leadership and oversight of all P20 SPORE activities involving Research Projects, the Biospecimen
Core, Patient and Community Engagement Core and the Developmental Research Program as well as a
seamless integration with the Cancer Center overall; 2) facilitating communications between P20 SPORE
participants, the National Cancer Institute, and the general public, and fostering intra-SPORE and inter-SPORE
interactions; 3) overseeing fiscal and resource management for each component of the P20 SPORE; 4) ensuring
compliance with all NIH and institutional grant regulations; 5) developing measures to evaluate the progress and
effectiveness of each component of the P20 SPORE as well as the overall effectiveness of the P20 SPORE in
cancer health disparities; 6) soliciting guidance and objective feedback from the Internal and External Advisory
Boards, P20 Cancer Action Council, and coordinating those meetings, including the Annual SPORE Research
Retreat; and 7) providing central guidance in transitioning the P20 planning grant to a full P50 SPORE
application.
The Administrative Core contributes to the overall efficiency of the P20 SPORE by leveraging the existing
administrative infrastructure of KCI, an NCI-designated Comprehensive Cancer Center, for the successful
management of the numerous projects, led by Drs. Schwartz and Bepler, MPIs of this application. This strong
administrative infrastructure will enable investigators to focus on the science of cancer health disparities.

Public health relevance
Project Narrative The Administrative Core provides the leadership and administrative infrastructure to support P20 SPORE-related activities, provides fiscal and regulatory oversight, and coordinates mechanisms of feedback, evaluation, and official communication with both the NCI and the community. This Core enables scientists to focus on their research by providing efficient overall management. Most importantly, the Core sets the vision and direction of the P20 SPORE within NCI’s SPORE Program.